Validating Novel Outcomes to Enable Systemic Sclerosis Calcinosis Cutis Clinical Trials

ABSTRACT:
About 40% of patients with systemic sclerosis (SSc) develop calcinosis cutis/calcinosis (painful calcium deposits
in the skin), that are a leading cause of physical impairments. Many treatments are currently prescribed including
sodium thiosulfate, yet there are no high-quality data to support use of any treatment. Before SSc-calcinosis
clinical trials can be conducted, quantitative outcomes to measure change over time are needed. The goal of
this proposal is to test the performance of two quantitative outcomes for SSc-calcinosis: the Mawdsley Calcinosis
Questionnaire and a quantitative CT imaging outcome for calcinosis. Fifty-six patients will be recruited from the
Yale Scleroderma Program, through advertisements posted on three websites: one internal and two external
(the National Scleroderma Foundation and the Scleroderma Research Foundation), from colleagues in New
York City and Rhode Island, and with mailed advertisements to members of regional rheumatology and
dermatology professional societies. Patients with symptomatic calcinosis will be recruited who desire treatment
for a calcinosis region of interest (ROI) that they will define. Patients will receive topical or intralesional (according
to protocol) sodium thiosulfate, a proposed calcinosis therapy with promising effectiveness data, to ensure that
calcinosis change occurs during the study. At baseline, 3-, and 6-months, research participants will complete the
Mawdsley Calcinosis Questionnaire (MCQ), a newly developed and partially validated instrument, as well as a
calcinosis visual analog scale (VAS). They will undergo CT of the ROI (baseline and 6-months) and calcinosis
volume will be quantified using open-source BioImageSuite Web Software developed at our institution. In
patients with symptomatic SSc-calcinosis who receive STS treatment for six months, we will test two aims. In
Aim 1, we will evaluate the performance of the MCQ as the primary outcome compared to the calcinosis VAS.
In Aim 2, we will measure change in the MCQ (or the calcinosis VAS depending upon the performance of the
MCQ in Aim 1) compared to quantitative CT imaging outcomes. The results of the present proposal will be used
to inform the design of future clinical trials to test the efficacy of sodium thiosulfate and other rationale therapies
for calcinosis. This proposal is significant because: 1) calcinosis is a leading cause of decreased health-related
quality-of-life in patients living with SSc, 2) no treatment guidelines have been developed to inform medical
decision-making because no Phase 3 clinical trials have ever been conducted; 3) quantitative outcomes need to
be validated to pave the way to calcinosis clinical trials. The innovation in this proposal lies in: 1) an independent
performance evaluation of the MCQ for measurement of the impact of calcinosis on SSc patients’ feel and
function and its responsiveness to calcinosis change in patients receiving STS, 2) assessment of our
BioImageSuite software for regional and serial quantification of calcinosis on CT. Our team is comprised of SSc,
imaging, musculoskeletal radiology and biostatistical experts. The environment is conducive to the successful
completion the studies who results will form the basis for the first Phase 3 trial ever conducted for SSc-calcinosis.

Public health relevance
PROJECT NARRATIVE: Symptomatic calcinosis cutis (calcinosis) occurs in 40% of patients with systemic sclerosis (SSc) and is a leading cause of functional impairments that decrease health-related quality-of-life. Many therapies are currently prescribed to treat SSc-calcinosis, yet a large Phase 3 trial to test any of these potential therapies has never been conducted (to our knowledge), in part, because validated outcomes are lacking. We propose to conduct a prospective, observational study of SSc patients with symptomatic calcinosis who will commence therapy with sodium thiosulfate, a chelating agent with considerable effectiveness data, and test the performance of two novel quantitative SSc-calcinosis outcomes: the Mawdsley Calcinosis Questionnaire and our open-source BioImage Software Suite tools applied to computed tomography exams of involved skin that permit quantification of calcinosis change over time.